Targeting Cdc42 in leukemia stem cells

The goals of this project are to use genetic means to demonstrate that the Rho GTPase, Cdc42 constitutes a novel target in leukemia stem cells (LSCs). The Cdc42 signaling axis lies at the crossroads of many signaling events and the functional interaction between Cdc42 and many of its implicated effectors mediate a variety of physiological responses including actin cytoskeletal reorganization, adhesion, migration, survival, and proliferation, of blood stem/progenitor cells. Cdc42 has been suggested to mediate Ras-transformation by signaling through growth factor receptors and to transduce cytokine signals into the nucleus to impact on cell proliferation. In the preliminary results, we have built up a basic conceptual framework suggesting that Cdc42 targeting can inhibit leukemia stem cell adhesion and engraftment, promote LSC mobilization from the bone marrow, and induce LSC apoptosis, in mouse models. We have also generated and established a collection of important reagents, mouse models, and methodologies including a conditional gene targeted mouse model, a human stem/progenitor transformed acute myeloid leukemia xenograft model in “humanized” mice, and Cdc42 mutant reconstitution/xenotransplantation add-back methods in defining the requirement of immediate signaling pathways regulated by Cdc42. In this proposal, we will test the hypothesis that Cdc42 is essential for the maintenance of LSCs in the BM niche and represents a novel therapeutic target for leukemia eradication. We will (1) genetically validate Cdc42 as a target in murine AML onset and progression by conditional gene targeting and mutant reconstitution approaches;and (2) determine the effect and molecular mechanisms of Cdc42 knockdown on human AML progression in a humanized mouse model. Our studies may implicate Cdc42 as a critical nodal of intracellular signal flows from multiple stimuli involved in leukemia stem cell maintenance in the bone marrow niche. The results will bear direct therapeutic value that pharmacologic targeting of Cdc42 in LSCs may allow for more effective combinatory chemotherapy in the effort to eradicate leukemia.

Public health relevance
Project Narrative Cdc42 GTPase and leukemia stem cells have emerged as potential anti-cancer therapeutic targets by recent studies. The proposed work will pursue genetic and pharmacologic targeting of Cdc42 to benefit leukemia therapy by introducing a novel concept that targeting Cdc42 in leukemia stem cells could result in their mobilization from the niche and this could serve as a new means in combinatory therapy. The studies will translate the mechanistic information obtained from the decades-long biochemical, cell biological, and genetic studies of Cdc42 and leukemia into future therapy.